Bridging Research Infrastructure for Dementia Gaps in East Africa (BRIDGE-AFRICA)

Project Summary
The proposed work will build research infrastructure for Alzheimer’s disease and related dementias
(ADRD) in East Africa. We build on MPI Valcour’s, 10-year history of cognitive research in East Africa and
activities of the Atlantic Fellows for Equity in Brain Health (AFEBH) program at UCSF, led by Valcour and
Miller (see LOS), which has an 8-year history of investment in training ADRD researchers in the region. To
date, AFEBH has trained 34 Atlantic Fellows in Africa, including three working in Kenya and nine working
in Ethiopia. These include MPI Zewde working at the University of Addis Ababa and MPI Udeh-Momoh
leading research at Aga Khan University in Nairobi. The proposal leads with a harmonized cognitive and
clinical assessment protocol across two countries in a manner that can become scalable across Africa
within the unique Atlantic Fellow network. During the UG3 phase, we will create the tools and demonstrate
feasibility for a harmonized two-country intervention-ready cohort of representative community dwelling
individuals at risk for ADRD. This work will include finalizing the creation of a harmonized multidomain
cognitive assessment battery underway and supported by UCSF’s AFEBH program and the fortification of
collaborative community outreach teams to inform culturally appropriate research enrollment and
procedure practices. We will continue to train new African AFEBH at UCSF at no cost to this proposal. In
the UH3 phase, we will build out cohorts of 200 controls, 50 patients with dementia, and 200 individuals at
risk for ADRD in each country, resulting in 900 total enrollees for future intervention trials. During this
phase, we will optimize ADRD diagnostics through examination of culturally adapted cognitive and
functional assessment tools in our harmonized battery and plasma biomarkers. Through community
engagement, we will determine optimal approaches for dementia prevention leveraging targets highlighted
in published modifiable risk factors (e.g., hypertension, physical activity, cognitive stimulation) and
determine feasibility in preparation for independent research grant applications (e.g., R01s) focused on
multidomain prevention strategies. The application draws further support from the Alzheimer’s Association
in the U.S., who has partnered with the AFEBH program at UCSF for 8 years to provide competitively
reviewed pilot funds allowing fellows to work in their region ($3.4 M to date). They will also continue to co-
deliver with the AFEBH program an international conference to be held in Cape Town, South Africa in 2024
with two additional conferences in Africa in support of this proposal (see LOS, no cost to this proposal).
Together, this intensive effort will create the tools and cohorts needed to for substantial neuroscience
development for ADRD in Africa.

Public health relevance
PROJECT NARRATIVE The proposed work will create deeply phenotyped, population representative cohorts of older adults in Ethiopia and Kenya in preparation for multidomain interventions to prevent Alzheimer’s disease and related dementias. Work will also create tools for dementia diagnostics, identify region-specific determinants of cognitive impairment and decline, and develop culturally appropriate and feasible dementia prevention approaches for this region.